Neural mechanisms of psychological risk on mother and infant adjustment in African American and European American families

Abstract
One of the major contributions of developmental psychology is the demonstration that early caregiving
experiences within the normative range (i.e., sensitive caregiving) not only contribute to offspring’s mental and
physical health disparities, but also that such associations are enduring over the life course. Research by the
PIs and others has identified brain mechanisms by which key maternal risk factors—depressive symptoms and
attachment insecurity—undermine caregiving behavior. However, given evidence documenting significant
change in the maternal brain over the transition to motherhood, there is a critical gap as to whether this transition
serves as a sensitive period during which maternal neural responding to infants is particularly impacted by
maternal depressive symptoms and insecurity that pose risk for caregiving behavior and infant adjustment.
Moreover, the majority of research has focused exclusively on mother-driven effects, limiting understanding of
the significance of infant characteristics for the maternal brain. Additionally, research on the maternal brain
primarily comprises samples of European ancestry women, thus, little is known about whether such processes
operate similarly in families of color. Therefore, this R01 application seeks to programmatically investigate
whether maternal psychological risk undermines maternal sensitivity and, in turn, infant adjustment via negatively
impacting change in maternal brain responding to infants over the transition to motherhood. Further, we will test
the role of infant characteristics (i.e., negative emotionality) in moderating this pathway. Critically, we include
expectant nulliparous European American (n=200) and African American (n=200) women to explore moderation
of our findings by maternal ethnicity. We further propose to identify person (parenting/emotion beliefs),
community (kinship/social support), and structural (discrimination) factors relevant to African American women
that may impact their neural adaptation to motherhood – comparing these findings to European Ancestry women.
We will examine maternal risk factors (depressive symptoms, attachment insecurity), multi-level factors relevant
to African American women, and brain responding to infant cues prenatally (3rd trimester) and postnatally (4 and
8 months). Postnatal assessments will include caregiving behavior (4, 8, and 12 months), infant negative
emotionality (4 and 8 months), and infant adjustment (12 months), including attachment security and behavior
problems. Our approach is innovative given its intergenerational, prospective, multi-level, and multi-time point
design and the ethnic diversity in the maternal sample enrolled. Our findings will inform models of the changing
maternal brain from pregnancy to the postpartum period and how maternal depression and attachment insecurity
may pose risk for maternal caregiving and infant adjustment as a function of infant negative emotionality and
maternal ethnicity. Furthermore, our approach will allow for more targeted intervention strategies for women
during their transition to motherhood to optimize mother and child well-being.

Public health relevance
Project Narrative Maternal psychological risk, characterized as depression and attachment insecurity, negatively impacts caregiving behavior and infant well-being. Increasing research suggests that neurocognitive mechanisms underscoring maternal sensitivity may represent one pathway through which maternal psychological risk affects caregiving and infant adjustment – although this research is generally limited by focusing largely on European ancestry women. Therefore, the proposed study seeks to examine whether maternal risk factors undermine maternal sensitivity and infant adjustment (including attachment security and behavioral problems) as a function of infant temperament through measurements of maternal brain functioning across the transition to motherhood in 200 European American and 200 African American nulliparous expectant mothers and their children.